Cancer Genetics Program

Cancer Genetics Program: Summary
The overall mission of the Cancer Genetics (CG) Program is to conduct innovative basic and translational
research on the genetics of cancer susceptibility, tumorigenesis, and disease progression. The CG Program
themes bring together experts in advanced genomic, genetic, and computational analysis methods to identify
abnormalities in genetic architectures that contribute to cancer pathogenesis. The goals of the CG Program are
carried out through three themes:
Theme 1: Determining the Impact of Germline Genetics on Cancer Susceptibility, Progression, Treatment
Choices, and Response
Theme 2: Exploiting Somatic Tumor Genomic Events for Precision Medicine Drug Development and Targeted
Therapy
Theme 3: Developing New Biological Insights and Combinatorial Therapies through Systems Views of Cancer
CG Program: Key Metrics
Membership (20 departments, 3 schools) 40
Full 27
Associate 13
Cancer-relevant Funding (direct costs as of
$20,450,174
05/31/2017)
NCI $8,976,865 44%
Peer-reviewed $3,899,508 19%
Non-peer-reviewed $7,573,801 37%
Cancer-relevant Publications (1/2012-7/2017) 666
Inter-programmatic 298 45%
Intra-Programmatic 141 21%
High-Impact 213 32%
Accruals to Clinical Trials (2016) 0 0
Therapeutic 0 0
Other Interventional 0 0
Non-interventional 0 0